Use of Telemedicine in the Treatment of Mental Illness

PROJECT SUMMARY
Access to mental health specialists is limited for many patients in the U.S., particularly for those who live in
rural or other underserved communities. Telemental health is one potential solution for this access problem.
Prior to the COVID-19 pandemic, use of telemental health was growing in rural communities, but overall use
was still low. During the public health emergency (PHE), use of telemental health increased dramatically across
the U.S., and telemedicine currently accounts for the majority of mental health visits. Now that most clinicians
and patients in treatment have tried telemental health, it is unclear how they will choose to incorporate this
technology into clinical care after the PHE ends. In this renewal we seek to understand the future role of
telemental health in mental health treatment and its relationship to access, equity, and quality of care.
In the first four years of our mixed-method R01, we made substantial progress in understanding how
telemental health is being used in real-world settings. We described its growth, how use varied substantially
across communities, and whether it had reduced urban-rural disparities in care pre-COVID-19. In the last year,
we pivoted to understanding the role that telemental health has played during the PHE and we worked directly
with health plans, state government, and the federal government to inform policy decisions. Building off this
foundation, we seek a renewal of our RO1 to understand how use of telemental health changes mental health
practice after the PHE ends and the association of these new practice models and quality of care. Under the
first aim, we seek to inform ongoing policy debates on reimbursement, licensure, and regulations by measuring
differences in telemental health use in response to post-PHE changes in regulation and reimbursement. There
has been considerable debate on whether telemental health will increase or decrease disparities in care. In the
second aim, using both quantitative and qualitative analyses, we will assess the role of telemental health in care
for disadvantaged populations and what is being done to address disparities. Under the third aim, we will
explore how telemedicine has changed how clinicians treat major depression and bipolar-I disorder, illnesses
representing different (on average) severity and chronicity, and, in the fourth aim, whether different telemental
health patterns are associated with improved or worse outcomes. We will use a mixed methods approach that
incorporates into each aim both quantitative analyses of Medicare, Medicaid, and commercial insurance claims
data and qualitative interviews (either of providers or patients).
Understanding how telemental health is incorporated into mental health treatment after the PHE, whether its
use worsens or narrows existing disparities in care, the role of regulation and reimbursement in telemental
health use, and whether different patterns of use are associated with higher quality care will help influence the
ongoing policy debate on telemental health. Together the results of these aims are consistent with the NIMH’s
expressed interest in innovative delivery models that can improve care for underserved communities.

Public health relevance
PROJECT NARRATIVE Telemedicine for the treatment of mental illness (or “telemental health”) is one way to improve access to mental health care for those who need it. Use of telemental health dramatically increased during the COVID-19 pandemic. In this renewal, we will study the period after the public health emergency ends to assess how different state laws and regulations influence the use of telemental health, whether increased use of telemental health has increased access for disadvantaged minorities and rural patients, how telemental health is being used in care, and whether its use is associated with improved quality of care.